Purinergic modulation of the autoimmune vascular phenotype

PROJECT SUMMARY/ABSTRACT
This proposed renewal of “Purinergic modulation of the autoimmune vascular phenotype” builds upon 4 years
of discovery by an early stage investigator in the areas of lupus, COVID-19, and antiphospholipid syndrome
(APS). Despite the routine use of traditional anticoagulants in the latter disease, 1 in 5 APS patients is still
expected to experience a breakthrough thrombotic event. Furthermore, anticoagulants do little to mitigate the
chronic occlusive microangiopathy that damages APS organs over time. How to combat anticoagulant-
resistant manifestations of APS is unknown. This project now endeavors to use a deeply-phenotyped patient
cohort, selected in vitro systems, and the most relevant animal models to identify adjuvant therapeutic
approaches for the APS clinic. Its successful completion will shed additional light on neutrophil phenotypes in
APS and will provide a new understanding of the role that purinergic signaling, neutrophil-platelet interactions,
and neutrophil metabolism play in thrombotic events. The goal is that by the next cycle of this grant, we will
have identified the 1-2 most promising drug candidates for repurposing in our APS clinic.
APS is a leading acquired cause of both thrombosis and late-term pregnancy loss. In pursuit of a mechanistic
understanding of immunothrombosis in APS, our group was the first to show that neutrophil extracellular traps
(NETs, tangles of chromatin and microbicidal proteins expelled from activated neutrophils via “NETosis”) are
required for APS-associated thrombosis. Since our last competitive submission, we have found that
extracellular adenosine generated by the ectonucleotidase CD73 restrains NET release by activating surface
adenosine A2A receptors (A2AR) and thereby boosting intracellular cAMP. Key preliminary data that inform this
renewal demonstrate (i) restraint of platelet-mediated neutrophil activation by the CD73-A2AR axis; (ii)
exaggerated thrombosis in myeloid lineage-specific A2AR knockout mice; (iii) hyperactive glucose metabolism
in APS neutrophils that normalizes with A2AR agonists; and (iv) mitigation of thrombosis in APS mice by
metabolism-focused interventions. The hypothesis is that manipulation of the CD73-A2AR-cAMP axis will
restore neutrophil homeostasis in APS. Specific Aim 1 will define mechanisms by which purinergic signaling
influences neutrophil and platelet function in APS. This Aim will define for the first time the purinergic
landscape of a thrombophilic disorder, elucidate mechanisms by which purinergic signaling regulates
neutrophil-platelet communication, and potentially identify the subset of APS patients most likely to benefit from
antiplatelet and/or adenosine receptor-modulating therapies. Specific Aim 2 will determine the extent to which
purinergic signaling can be leveraged to normalize neutrophil metabolism in APS. This Aim is expected to
provide a new understanding of the metabolic requirements of NETosis, elucidate strategies for manipulating
neutrophil metabolism, and identify the subset of APS patients most likely to benefit from those strategies.

Public health relevance
PROJECT NARRATIVE Antiphospholipid syndrome (APS) is a leading cause of blood clotting and is triggered by abnormal antibodies that activate immune cells and thereby damage blood vessels. This proposal investigates a natural mechanism by which enzymes convert harmful molecules released from dying cells into a substance called adenosine that protects blood vessels from inflammation. The goal of this work is to harness these protective pathways to protect against the devastating effects of APS in patients.